Cell Procurement & Processing

PROJECT SUMMARY/ABSTRACT - Cell Procurement and Processing Core
The purpose and objective of the Cell Procurement and Processing (Cell P&P) Core remains to advance the
understanding of hematopoiesis and nonmalignant disorders through the distribution of high-quality
hematopoietic products to the hematology research community. To meet this need, the early precursors of
Cell P&P Core was first established in 1999 under the original CCEH P30. Over the almost 20-year history,
The Cell P&P Core has become recognized as a national resource for normal hematopoietic cell products, as
evidenced by the 171 investigators at 69 institutions who have received hematopoietic products during the
previous award period. Moreover, utilization of resources from the Core have continued to grow and facilitate
investigations that have advanced our understanding of the biology governing normal hematopoiesis and
nonmalignant disorders. As part of the proposed award, the Cell P&P Core will leverage its expertise,
infrastructure, and experiences to increase production and utilization of the high-quality products to advance the
field of hematology research, while maintaining the current high standards for product quality as detailed in the
Research Strategy. Therefore, the Cell P&P Core proposes the following:
Specific Aim 1. Expand the number of users for enriched hematopoietic cell products of the highest
quality and uniformity to facilitate hematology research. We propose three new approaches to increase
user numbers. 1) The Cell P&P Core develop a novel User Satisfaction and Needs Program to provide
feedback and identify new users. 2) The Core will develop Virtual Workshops targeting existing and new
users. 3) The Core will develop a novel funding mechanism called Cell P&P New Investigator Award that
provide resources at significantly reduced prices. Specific Aim 2. Develop user-friendly, integrative and
comprehensive Data Management System (DMS) for hematopoietic specimens. The proposed DMS will
incorporate real-time assessment for tracking and retrieval of donor characteristic, pre-analytic variables,
SOPs, inventory, quality controls, quality assurances, and specimen distribution, which will have two major
beneficial effects. 1) The Core will be able to more efficiently provide users with the essential variables related
to their research. 2) The Core will be able to more rapidly and comprehensively assess quality measures and
evaluate potential variables impacting product uniformity. Specific Aim 3. Develop new and innovative
user-directed products to facilitate hematology research. Given the explosion of new technologies to
examine hematopoietic cells, it remains a challenge for investigators to acquire the skills to take advantage of
these technologies. By combining the expertise of Cell P&P and Tool Cores, we will be able to efficiently
develop and deliver user-directed products to those investigators who may not otherwise be able to develop
these products within their labs. Through these deliverables, we will broaden the research potential for these
investigators and provide a mechanism to increase hematology research.